Three-Dimensional Organoid Cultures to Investigate 3q26 Driver Functions in Multiple Lung Cancer Cells of Origin

SUPPLEMENT PROJECT SUMMARY Lung squamous cell carcinoma (LSCC) is a major sub-type of lung cancer. LSCC tumors can be further sub- classified into four distinct molecular subtypes: primitive, classical, secretory and basal based on expression profiling. The LSCC molecular subtypes share similarities in gene expression profiles with distinct lung epithelial cell populations suggesting that the LSCC molecular subtypes may originate from different lung epithelial cell populations. Genomic analysis of human LSCC pre-neoplastic lesions and tumors demonstrates that 3q26 copy number gains (CNGs) and TP53 mutations are among the most prevalent early genetic alterations in LSCC, suggesting that these genetic events play an important role in the initiation and progression of LSCC. Furthermore, interrogation of The Cancer Genome Atlas (TCGA) LSCC database reveals that 3q26 CNGs are present in all four LSCC molecular subtypes suggesting that 3q26 CNGs may play a role in the molecular signaling pathways that drive the pathogenesis of these molecular subtypes. Our studies have shown that the genes SOX2, PRKCI and ECT2 are key targets of 3q26 CNGs that functionally collaborate in maintaining the transformed phenotype of human LSCC cells. Our more recent studies have demonstrated that overexpression of SOX2, PRKCI and ECT2, in the context of Trp53 loss, is sufficient to; 1) transform mouse lung basal stem cells (LBSCs) (a cell of origin for LSCC); and 2) drive formation of LBSC tumors with LSCC-like histopathology in vivo. Based on these observations, we hypothesize that co- overexpression of SOX2, PRKCI and ECT2 and Trp53 loss can cooperate to transform other putative LSCC cells of origin to develop LSCC-like tumors that exhibit signaling pathways observed in the four human LSCC molecular subtypes. This hypothesis will be tested through two interrelated specific aims designed to; 1) assess cooperative oncogenic activities of SOX2, PRKCI and ECT2 on the transformation of putative LSCC cells of origin; and 2) determine the mechanisms underlying the roles of SOX2, PRKCI and ECT2 in lung epithelial cell transformation and LSCC development. Successful completion of these aims will provide important mechanistic insight into the molecular heterogeneity of LSCC and offer novel pre-clinical models to identify and evaluate therapeutic targets in distinct molecular subtypes of LSCC.

Public health relevance
SUPPLEMENT PROJECT NARRATIVE Lung squamous cell carcinoma (LSCC) is a major form of lung cancer characterized by poor prognosis and therapeutic response. Copy number gain (CNG) in chromosome 3q26 is a hallmark genetic alteration in LSCC which drives the coordinate overexpression of its resident oncogenes, SOX2, PRKCI and ECT2. This project will investigate the cooperative oncogenic activities of SOX2, PRKCI and ECT2 in different putative LSCC cells of origin, which will provide mechanistic insight in the roles of cells of origin in defining the molecular subtypes of LSCC and help to identify distinct therapeutic vulnerabilities in the LSCC molecular subtypes.